Tumor-Activated Dual Payload-Drug Conjugates

PROJECT SUMMARY/ABSTRACT
Targeting the hallmark biomarker prostate specific membrane antigen (PSMA) has been a successful small
molecule drug-delivery strategy for various payloads to prostate tumor cells, which is evident in the FDA's
recent approval of 177Lu-PSMA-617 and the clinical advancement of our 18F-CTT1057 (an irreversible-binding
phosphoramidate-based) PSMA-targeted PET-imaging agent (NCT04838626, NCT04838613). However,
efforts to develop PSMA-targeted chemotherapeutic nanomedicine have had limited clinical therapeutic
efficacy. Our long-term goal is to develop a versatile and intelligently designed platform for the selective
delivery of synergistic therapeutic payloads to offer novel treatment options for lengthening and improving the
quality of life for metastatic castration-resistant prostate cancer (mCRPC) patients. The overall objective of this
project is to develop a PSMA-targeted small-molecule dual drug conjugate (SMDDC) to serve as a companion
therapeutic to our PSMA-targeted PET-imaging agent (NCT02916537, NCT03427476). Our central hypothesis
is that tumor-site activation and release of two distinct chemotherapeutic payloads for prostate cancer can be
achieved and will be more effective than small molecule drug conjugates (SMDCs) releasing only a single
chemotherapeutic payload. The rationale for developing SMDDCs is to set the groundwork for a new, dual-
drug therapeutic strategy for patients with mCRPC and advanced malignancies with PSMA(+) neovasculature.
Two specific aims will be pursued to test the central hypothesis: 1) Assess the spatio-temporal cargo-release in
prostate tumor cells with a PSMA-targeted small-molecule dual probe conjugate (SMDPC); and 2) Determine
the potency enhancement of a SMDDC bearing dual payloads in prostate cancer cell lines. For Aim 1,
PSMA(+) and PSMA(-) prostate cancer cell lines will be used to assess the spatio-temporal cargo-release of a
PSMA-targeted SMDPC bearing two distinct turn-on probes, 7-Amino-4-methylcoumarin and hydroxymethyl
rhodamine green. Established PSMA activity assays will be used to determine the IC50 and mode of binding for
the PSMA-targeted SMDPC. In Aim 2, in vitro effectiveness of an SMDDC bearing both MMAE and Exatecan
vs. an SMDC bearing either MMAE or Exatecan alone will be evaluated in PSMA(+) and PSMA(-) prostate
cancer cell lines. The proposed work is innovative because it aims to utilize a unique combination of drug-
delivery strategies; PSMA-ligand promoted internalization, a novel acid-labile linker for pH-triggered drug
release, and two distinct chemotherapeutic drugs with differing mechanisms of action. This will be a significant
achievement because it will provide proof-of-concept for developing clinically relevant chemotherapy for
mCRPC and other malignancies with PSMA(+) neovasculature. Future plans include expanding the selection
of drug payloads for PSMA-targeted SMDDCs and initiate preclinical IND-enabling studies. The expected
positive impact of these studies is that they will, in all likelihood, set the foundation for a general, dual-drug
strategy for targeted chemotherapy for other biomarker-characterized diseases.

Public health relevance
PROJECT NARRATIVE While PSMA-targeting has been a successful imaging and drug-delivery strategy for various payloads to prostate tumor cells, there is a need to overcome the challenges of tumor heterogeneity and drug resistance in order to provide treatment options for metastatic castrate-resistant prostate cancer (mCRPC) patients, especially those that relapse or fail to meet the requirements for radiotherapy. A PSMA-targeted, pH- responsive small molecule dual drug conjugate that bears two different chemotherapeutic drugs with different mechanisms of action and simultaneously releases both drugs upon internalization in tumor cells is anticipated overcome these challenges. This project aims to develop a new class of PSMA-targeting agents to meet the need for efficiently and selectively treating mCRPC patients and other PSMA(+) neovasculature cancers, as well as set the foundation for a general, dual-drug strategy for targeted chemotherapy for other biomarker- characterized diseases.